CAFFEINE IN DIAZOXIDE INDUCED RENIN RELEASE IN BETA-BLOCKED NORMAL SUBJECTS

The purpose of this study is to determine whether caffeine effects renin release indirectly via increased sympathetic activity or directly within the kidney.